Pharmacological Sciences Training Grant

DESCRIPTION (provided by applicant): This proposal outlines a Pharmacological Sciences Training Program (PSTP) for years 40-44 at Duke University. The goal of the PSTP is to prepare Ph.D. candidates to use Pharmacology in their careers as active research scientists in leadership roles. This is an interdisciplinary training program composed of students from an innovative triumvirate of Departments of Pharmacology and Cancer Biology, Chemistry and Biomedical Engineering. Leadership in the program is provided by a Director, Co- Director, Executive, Admissions, Curriculum Committee and Trainee Review Committees. Participating faculty are selected on the basis of research interest in Pharmacology and enthusiasm for participating in Program activities including advising Ph.D. students, participation on student committees, classroom teaching, student advising and survival skills mentoring. The training includes coursework in four core courses (Essentials of Pharmacology and Toxicology, Interdisciplinary Approach to Pharmacology, Drug Discovery and Biostatistics) and laboratory research related to Pharmacology. Students also receive training in oral and written presentations in multiple venues including core classes, student seminar, the Pharmacology and Cancer Biology department retreat and attendance at national meetings funded by the training grant. This training is integrated with requirements of the students' specific discipline. Training in Responsible Conduct is a required part of the curriculum. The program sponsors a monthly Survival Skills luncheon for all trainees and students are introduced to the wide array of professional development opportunities offered by Duke University. The Executive Committee selects candidates based on interest in Pharmacology, excellent undergraduate record, strong GREs and outstanding recommendations. The program in Pharmacological Sciences has a long-standing, active and effective minority recruitment program which integrates with strong programs from the University and the Biomedical Sciences.

Public health relevance
PUBLIC HEALTH RELEVANCE: The purpose of this proposal is to provide training in Pharmacological sciences to PhD candidates in Pharmacology and Cancer Biology, Chemistry and Biomedical Engineering. The training includes 4 core courses, laboratory research, training in presentation skills, professional development and training in Responsible Conduct of Research. The program actively recruits and mentors individuals from underrepresented minorities.